Developing tools to study relationship between oxidative stress in T cell dysfunction

Abstract
In response to chronic viral infection or in tumor microenvironment, antigen(Ag)-specific CD8 T cells
undergo alternative activation processes, called exhaustion. Exhausted CD8 T cells lose their proliferation and
effector gene expression, thus allowing viral infection or tumor growth to persist despite the initial expansion of
antigen-specific clones. Although the precise mechanism driving T cell exhaustion is unknown, literature
suggests that exposure of T cells to excessive oxidative stress contribution to the establishment of exhaustion.
In this small grant, we propose to generate genetically modified mice that facilitate visualization of cells that are
exposed to oxidative stress and use the tools for future studies for T cell exhaustion.

Public health relevance
Project Narrative CD8 T cells play central roles in controlling intracellular pathogen and cancers but undergo alternative differentiation known as exhaustion. We propose to generate new tools to study T cell exhaustion by visualizing oxidative stress response.